Deciphering the Immune Evasion Mechanisms in Mutant IDH1 Cancer

Project Summary
Mutations in isocitrate dehydrogenase 1 (mIDH1) are prevalent in various solid tumors, including intrahepatic
cholangiocarcinoma (ICC), leading to the production of (R)-2-hydroxyglutarate (2HG). This oncometabolite
disrupts epigenetic and metabolic processes by inhibiting enzymes involved in DNA demethylation. I have
developed a genetically engineered mouse model (GEMM) that recapitulates the genetics and histopathologic
features of human mIDH1 ICC. I revealed that mIDH1 creates an immunosuppressive microenvironment in ICC
centered on dual 2HG-mediated mechanisms suppressing CD8+ T cell anti-tumor activity. These properties are
reversed by mIDH1 inhibition leading to reduced tumor growth associated with pronounced activation of immune
stimulatory interferon (IFN) signaling and CD8+ T cell recruitment and effector function. My progress reveals that
restoring antitumor immunity is central to mIDH1 inhibitor efficacy. However, we still have an incomplete
understanding of the basis of mIDH1-mediated immune evasion that must be addressed to advance my
mechanistic understanding and guide therapeutic development. My preliminary data suggest that mIDH1 ICCs
are 'immunologically cold' due to two distinct mechanisms: a tumor cell-intrinsic pathway that hampers
immunological recognition of the tumor cells and a paracrine program that curbs immune cell function. i) mIDH1
suppresses innate immunity: My research shows mIDH1 suppresses innate immunity, as evidenced by a low
type I IFN gene signature and silencing of the cGAS sensor. Conversely, AG120 rapidly induces endogenous
retrovirus (ERV) expression. Notably, cGAS and ERV-derived reverse transcriptase deletion blocks AG120
efficacy. ii) Metabolic crosstalk: My recent studies show that mIDH1 also impairs immune cell function via
metabolic crosstalk by affecting T cell effector function and macrophage polarization. My preliminary studies
suggest that these effects are due, in part, to the uptake of tumor-derived 2HG by these immune lineages as
well as by metabolic cross-competition, with mIDH1 driving high levels of glycolysis, potentially limiting nutrient
availability required for immune cell function. I aim to test whether these two processes collectively cause the
immune suppressive phenotype of mIDH1 tumors. This study will elucidate the biology of this oncogene, and my
data indicate that mIDH1 gliomas share common themes, suggesting a broader impact. I will focus on three
specific aims: 1) Decipher the role of viral mimicry in response to mIDH1 inhibition; 2) Explore the contribution
of metabolic crosstalk to immune evasion. These studies will offer novel insights into the mechanisms of mIDH1
inhibition in cancers, potentially leading to the development of more effective therapeutic strategies and
enhancing understanding of tumor-immune communication. To support this work, I have outlined a career
development plan to refine skills in laboratory management, knowledge dissemination, and securing independent
funding. Securing a K22 award will be instrumental in achieving my long-term goal of becoming an independent
researcher in cancer metabolism and immunology and will propel my pursuit of innovative cancer therapies.

Public health relevance
Project Narrative Cholangiocarcinoma is an epithelial cancer that originates from the bile ducts in the liver, characterized by a grim prognosis, steadily increasing incidence, and one of the most challenging prognoses in oncology. Leveraging a novel genetically engineered mouse model of IDH1 mutated cholangiocarcinoma and other innovative techniques, our proposed research aims to unravel two distinct mechanisms that render mIDH1 cancers immunologically cold: a tumor cell-intrinsic pathway hindering immunological recognition of the tumor cells, and a paracrine program that suppresses immune cell functionality. This study promises to illuminate enhanced strategies to treat this devastating disease and may extend to studying IDH1 mutations in other cancer types, such as glioma, or developmental diseases arising from gain-of-function mutations in IDH1.